ALL OF US EVENINGS WITH GENETICS RESEARCH EDUCATION PROGRAM

The All of Us Evenings with Genetics (EwG) Research Program, funded in part by the NIH All of Us Research Program, engages and trains trainees and faculty to utilize the All of Us database for research projects to advance precision medicine. The program has two core aims: 1) address barriers to research productivity for researchers aspiring to advance in STEM careers and 2) promote use of the All of Us database for research focused on closing health gaps and identifying factors behind variations in health outcomes. To achieve these goals the program implements three key activities: (1) Campus Seminars: hosted virtually at colleges and universities to connect faculty with the All of Us Research Program and showcase ongoing research, (2) Biomedical Researchers (BR) Faculty Summit: a multiday conference for researchers to foster collaboration and train participants in using the All of Us database, and (3) BR Scholars Program: A yearlong initiative supporting research teams formed at the summit in developing and executing projects using All of Us data. During the BR Scholars Program, the All of Us EwG program also offers data science training, mentorship, and professional development to the biomedical researchers.

Public health relevance
To address a lack of data science expertise among researchers, which limits their ability to tackle community-based issues in research with large databases like that from All of Us, we launched training on the All of Us data and the Researcher Workbench. This program effectively educates researchers regardless of their prior data science knowledge. By leveraging data in All of Us donated by U.S. citizens, these researchers will explore significant health gaps in the U.S. while also being equipped with the skills necessary to analyze data from large databases such as All of Us.